SR Fun Gen

The Functional Genomics Facility provides cDNA microarrays, Affymetrix oligo arrays, and computational and experimental support for investigators conducting studies of gene expression. The Facility also provides gene expression analysis using real time PCR. The real time PCR service is helpful to investigators conducting studies of gene expression profiling, copy number determination of DNA or RNA targets, siRNA knockdown validation, allelic discrimination/SNP genotyping, transgenic mouse genotyping, biodistribution studies of gene therapy products, and microbial detection. All CCSG supported core are organized into one group: Basic Research. This shared resource is catagorized as category (1.35) DNA array in summary ID

Public health relevance
The heart of cell operation lies in the expression of individual genes. This resource will enable analysis of genes in tumor cells and their normal counterparts to assist Cancer Center investigators in the identification of novel gene targets.